Improving Post-Acute Care Value for Veterans

Background: The transition to a skilled nursing facility (SNF) after an acute hospitalization is one of the most
perilous times in the life of an older Veteran. Veterans undergo more than 250,000 transitions between
hospitals and SNFs annually, but more than 1 in 4 is readmitted to the hospital from SNF and less than half
have returned to the community by 100 days following hospital discharge. Although the intent of SNF care is
to allow recuperation and rehabilitation, Veterans who do not successfully recover are commonly placed in
institutional long-term care at significant cost to themselves and to the VA, which spends more than $7 billion
annually on this care. However, SNFs vary widely in their rates of community discharge and costs of care
delivered. It is unclear how to identify “high-value” SNFs (those that deliver the best community discharge rates
at lowest cost) for Veterans since existing public quality metrics do not include VA SNFs, do not list Veteran-
specific outcomes, and do not include costs. Similarly, it is unclear how much matching individual Veteran
needs with particular SNF characteristics might improve value. The VA as both payer and provider of SNF
care has the unique opportunity to develop an optimal SNF network to drive high-value care.
Significance/Impact: This work aligns with VA priorities to develop an integrated, high-performing network for
Veterans as part of the MISSION Act and positions the VA as a leader in delivery of post-acute care. There
are more than 4 million Veterans currently over age 65, making it imperative to improve outcomes and lower
costs in SNFs as more Veterans transition out of the hospital to this care setting.
Innovation: The approach uses novel data sets and methods drawn from health economics, big data, and
systems engineering to provide new insights. To our knowledge, there are no published studies describing the
outcomes of Veterans in post-acute care, identifying characteristics of high-performing facilities, nor
establishing how matching patient to post-acute care provider characteristics affects outcomes.
Specific Aims: Our Specific Aims are to:
1) Compare outcomes (successful discharge to the community) and costs (Federal dollars) across the
population of Veterans discharged from a VA hospital to the three most common post-acute care
settings where Veterans receive SNF care: CLCs, CNHs, and non-VA SNFs.
2) Evaluate the effect of matching individual subpopulations of Veterans (e.g., by risk for adverse
outcome) to SNF type (CLCs, CNHs, or non-VA SNFs) and SNF star rating on outcomes and costs.
3) Compare the effects of consolidating SNF referrals to the SNF type with best outcomes and lowest
costs (Aim 1) or matching individual Veteran characteristics to different SNFs (Aim 2) on Veteran
outcomes, overall costs of care, and SNF capacity.
Methodology: This proposal uses advanced statistical techniques (such as instrumental variable and machine
learning methods) and a unique dataset (the 2014-18 Residential History File, which concatenates VA, fee-
basis, Medicare, and Medicaid data into longitudinal episodes of care for individual Veterans) to accomplish
our Aims.
Implementation/Next Steps: The results of this work will be disseminated to VA Geriatrics and Extended
Care and Office of Community Care leadership, who have been involved in the development of the proposal,
as well as VISN and VA facility leadership through two tools that can be used 1) at the bedside to optimize
SNF choice and 2) at a leadership level to help shape the SNF network to maximize value.

Public health relevance
More than 200,000 Veterans are discharged from the hospital to skilled nursing facilities (SNFs) annually, but more than 1 in 4 is readmitted to the hospital from SNF and less than half have returned to the community by 100 days following hospital discharge. Although the intent of SNF care is to allow recuperation and rehabilitation, Veterans who do not successfully recover are commonly placed in institutional long-term care at significant cost to themselves and to the VA, which spends more than $7 billion annually on institutional care. Veterans receive care in SNFs inside and outside the VA with different rates of success in returning them to the community. This project seeks to identify “high-value” SNFs (those that deliver the best rates of returning Veterans to the community for the lowest costs) across VA and non-VA facilities and understand how much “matching” a Veteran with specific needs to specific SNFs improves value. We then use what we have learned to build models for how the VA could create the highest-value SNF network possible.